Human milk metabolomics and microbe-host interactions associated with pediatric obesity

PROJECT SUMMARY/ABSTRACT
Pediatric obesity affects 1 in 3 children in the US and represents a public health crisis. Accumulating data
suggests maternal obesity may seed an “obesogenic” microbiome responsible for transmitting obesity risk from
mother to child. Exclusive breastfeeding is associated with protection against pediatric obesity; however, the
association between human milk components and the microbiome that account for these observations are poorly
characterized. Recent advances in metabolomics analysis provide a novel opportunity to investigate how the
human milk metabolome in combination with microbe-host interactions are associated with infant adiposity during
the first year of life. The Principal Investigator, Dr. Dominick J. Lemas, Ph.D. will use high-resolution mass
spectrometry as a tool to interrogate the human milk metabolome and infant microbiome in a longitudinal
maternal-infant cohort of obese and normal weight mothers that includes vaginally and cesarean section
deliveries. The over-arching hypothesis of this proposal is that the human milk metabolome will be associated
with changes in the early infant microbiome that alter risk for obesity and weight gain in the first year of life. In
collaboration with a multidisciplinary team of expert mentors (including primary mentor Dr. Christian Jobin and
co-mentors Drs. Josef Neu, Timothy Garrett, William Hogan, Janice Krieger), the primary goal of this K01 career
development proposal is for Dr. Lemas to develop expertise in high-resolution metabolomics, biomedical
informatics and longitudinal clinical microbiome studies. Specific Aim 1 will determine effective strategies for
recruiting pregnant and breastfeeding mothers into clinical microbiome studyes. Specific Aim 2 will characterize
the role of the human milk metabolome on the development of the infant microbiome. Specific Aim 3 will identify
how the human milk metabolome is associated with infant adiposity. The proposed research is focused on the
pathophysiology of infant growth and adiposity during early life and will inform subsequent studies that seek to
reduce the risk of pediatric obesity. As outlined in the Justification to Support Extension Request, the
COVID-19 pandemic significantly impeded the progress of Dr. Lemas’s K01 award through a combination
of delays, shut-downs and general loss of resources, personnel, and opportunities. Ultimately, the
COVID-19 pandemic resulted in a cumulative delay of 12-15 months in research and training progress.
We are requesting a 12-month extension that will allow Dr. Lemas to complete all project milestones including
the training plan that is designed to build an independently-funded clinical and translational research program
focused characterizing the microbe-host interactions that contribute to pediatric obesity, consistent with the
mission of the NIDDK.

Public health relevance
PROJECT NARRATIVE Pediatric obesity has more than doubled in children and tripled in adolescents over the past 30 years. Recent findings demonstrate that differences in energy harvesting bacteria promote obesity in the host and appear to be influenced by early life factors such as mode of delivery, maternal obesity, and breastfeeding. The goal of this proposal is to leverage untargeted metabolomics to investigate how human milk impacts the infant gut microbiome during the first 12-months of life and identify the microbe-host interactions that mediate the protective role of breastfeeding on infant adiposity.